Structural and functional studies of RNase MRP RNP

Project Summary
This project is focused on structural and functional studies of Ribonuclease (RNase) MRP. RNase MRP an
essential and universal site-specific eukaryotic endoribonuclease. It is a 450 kDa multicomponent catalytic
ribonucleoprotein (RNP) related to RNase P, but it has evolved to have a distinct substrate specificity and
unique cellular functions. RNase MRP is involved in the metabolism of a wide range of RNA molecules,
including rRNA and some mRNAs. In humans, altered RNase MRP activity results in a range of
developmental disorders that typically lead to an extremely short stature, brittle hair, predisposition to
cancers, and other abnormalities; the mechanisms causing these problems are not known as RNase MRP
remains understudied.
The specific aims of the proposal are:
1. Determination of the structural organizations of the S. cerevisiae RNase MRP holoenzyme using cryo-
electron microscopy (cryo-EM).
2. Characterization of interactions of yeast RNase MRP with its substrates.
This proposal will reveal the structure of RNase MRP and its divergence from its RNase P progenitor. It will
uncover the respective roles of RNase MRP RNA and proteins in the interactions with a diverse range of
substrates and clarify the mechanisms of RNase MRP substrate recognition and cleavage site selection,
paving the way to the characterization of RNase MRP cellular functions. These studies will have a broad
impact beyond the RNase MRP/P field by revealing the interplay of proteins and RNA in one of the most
complex RNP enzymes, and by advancing our understanding of the structure, function, and evolution of
catalytic RNPs.

Public health relevance
Project Narrative RNase MRP is a catalytic ribonucleoprotein complex essential for the survival of eukaryotic cells. Defects of RNase MRP cause developmental abnormalities in humans. Studying RNase MRP will help advance our fundamental understanding of this enzyme and the roles that it plays in health and disease.